Task B13: Evaluation of MCMs directed against BSL-4 Viruses in Non-Human Primates (NHPs)

This contract provides for the development and standardization of non-human primate models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.